Obstructive Sleep Apnea and Associated Pathologic Cardiovascular Phenotypes in Young Individuals: A Comprehensive and Longitudinal Analysis of At-Risk College-Aged Students

PROJECT SUMMARY/ABSTRACT
Obstructive sleep apnea (OSA) is highly prevalent across the age spectrum and associated with significant
cardiovascular (CV) diseases. To date, our understanding of the association between OSA and CV pathobiology
comes from limited cross-sectional data examining older individuals with severe OSA and advanced CV disease,
and recent clinical trials have demonstrated OSA treatment in this population does not improve CV outcomes
likely because of irreversible CV pathology. The effects of incident and developing OSA on CV phenotypes in
younger and healthier individuals remain unknown and whether OSA treatment in this population reverses early
CV pathophysiology is uncertain. In my K23, we have demonstrated that OSA is highly prevalent in collegiate
American-style football (ASF) athletes, which is a young and healthy population, but also enriched with early
traditional CV risk. Our data suggest that OSA in ASF athletes is associated with maladaptive CV functional
changes, reduced diastolic function and arterial stiffness; the combination which mirrors the pathophysiology of
ventricular-arterial (V-A) uncoupling. New preliminary data also suggest OSA is prevalent among higher-risk
female collegiate athletes. We will now leverage our access to at-risk young college-aged individuals to analyze
developing OSA and the corollary impact on CV function in absence of confounding and advanced CV morbidity.
The scientific premise for the proposed work lies in establishing the pathophysiology that leads to OSA-
associated CV disease. Understanding the natural progression of OSA disease could lead to new and effective
treatment options for healthier patients prior to irreversible CV pathology, thereby reducing the public health
burden of OSA. This prospective and observational cohort study will examine young individuals with OSA using
repeated measures analyses and will bring together a multi-disciplinary expert team of scientists from cardiology,
exercise physiology, and sleep medicine. We will use a comprehensive array of non-invasive testing including
cardiac imaging, vascular function analysis, sleep studies, and plasma metabolomics to characterize the effects
of incident and developing OSA on CV function. The working hypotheses are: 1) Independent of weight gain,
OSA leads to impaired diastolic function, arterial stiffening, and V-A uncoupling among at-risk young athletes
and non-athlete undergraduates with OSA, 2) Changes in OSA observed in detrained individuals will remain
associated with CV functional measures, independent of changes in weight, and 3) OSA leads to a specific
changes in metabolism that will be associated with CV dysfunction. Aim 1 will investigate the relationship
between incident OSA and diastolic function, arterial stiffness, and V-A coupling, adjusting for weight, in a large,
multi-center cohort of male ASF athletes, female athletes, and undergraduate controls. Aim 2 will assess the
relationship between CV dysfunction and OSA in detrained subjects adjusting for weight change and left
ventricular mass regression. Aim 3 will identify the metabolic profile associated with OSA and the association
between OSA-specific metabolites and early CV dysfunction.

Public health relevance
PROJECT NARRATIVE Obstructive sleep apnea (OSA) is common across the age spectrum, associated with significant cardiovascular disease, and represents a formidable public health burden in the United States. Currently, we lack understanding of the pathologic effects of incident and developing OSA on cardiovascular function in younger and healthier individuals with OSA, which could lead to improved risk stratification and treatments earlier in the disease course that impact later-life cardiovascular outcomes. Capitalizing on the strengths of an experienced, multi-disciplinary team, we will: 1) leverage our ability to study an important sub-group of young individuals at-risk for OSA and enriched with traditional early cardiovascular risk, which include young male and female collegiate athletes; 2) analyze the association between incident and worsening OSA and pathologic changes in cardiovascular function; and 3) assess the metabolic profile in young individuals with OSA that is associated with early cardiovascular pathophysiology.